Administrative Core (AC1)

Administrative Core (AC1) Abstract An administrative core has been part of this Program Project HL073311 entitled “Structure and Function of Beta3 Integrins on Blood Cells.” since its inception and will continue to execute the fiscal and administrative support necessary for the overall Program and the three individual Projects and other Cores to run smoothly and to perform the best science possible.